In vivo Imaging of the Human Retina at the Molecular Level

Project summary
The fluorescence lifetime measures the duration a fluorophore remains excited before returning to the ground
state by emitting a photon. It is an intrinsic property unique to each fluorescent molecule and its environmental
state. Fluorescence lifetime imaging ophthalmoscopy (FLIO) can perform in vivo lifetime measurements of
endogenous signals in the retina and retinal pigment epithelium (RPE), ranging from vitamin A derivatives in
lipofuscin (LF) to flavin-adenine-dinucleotide (FAD) in mitochondria. As many fluorescent molecules have been
implicated in aging and age-related macular degeneration (AMD), FLIO promises precise measurements of the
metabolic status and oxidative stress levels in retinal layers/cells. With three Specific Aims, we propose to
develop cellular-level FLIO. First, we will marry FLIO with state-of-art adaptive optics (AO) to overcome the
eye’s optical imperfections and create adaptive optics (AO) enhanced FLIO (AOFLIO). We will develop
AOFLIO on an AO scanning laser ophthalmoscope (AOSLO), a retinal imaging instrument with proven cellular
resolution. The AOFLIO instrument will achieve diffraction-limited image resolution (~2 μm lateral, ~ 30 μm
axial) over a 7º X 7º FOV in a single frame; this is ~21 times larger than that of the current AOSLO. Further,
We will fortify AOFLIO with novel image-processing strategies to quantitatively resolve the complex mix of
colors and lifetimes of retinal and RPE fluorophores. The improved processing capabilities of phasor analyses
of fluorescence lifetimes will permit superimposed signals from multiple molecular species to be unmixed and
permit imaging with a meager light budget. We will leverage recent advances in the histology of the human
retina and RPE for in vivo analyses using FLIO to measure fluorophores within individual cells, specific layers,
and subcellular structures. Thus, AOFLIO promises the combined speed and resolution with an adequate field
of view (FOV) to offer a needed window into retinal function in normal physiology and disease. Second, we will
characterize and distinguish fluorescence signals with high spatial precision in normal human subjects and
establish a normative database of fluorescence lifetimes in different retinal layers and individual (photoreceptor
and RPE) cells in human subjects of age, gender, and race/ethnicity, thereby facilitating correlation with
leading candidates for signal sources. Third, we will use AOFLIO to characterize the metabolic function of the
retinal pigment epithelium (RPE) in AMD, a disease that causes vision loss in over 10 million older Americans.
Our study will focus on intraretinal hyperreflective foci (IHRF), the strongest predictor of the development of
late AMD, and investigate fundamental questions of IHRF pathogenesis and its role in the pathophysiology of
AMD. These Aims will help us improve retinal and RPE metabolic function assessment in normal aging and
AMD. The achievement will provide a foundation for future investigation of the pathophysiology of a broad
array of retinal and central nervous system diseases for which aging is a risk factor.

Public health relevance
Project narrative We will develop a high-resolution adaptive optics fluorescence lifetime imaging ophthalmoscope (AOFLIO) and use this instrument to characterize the fluorescence lifetime of fluorophores within individual cells or specific layers in the retina and its supporting retinal pigment epithelium (RPE) in the living human eye. Our study will provide precise localization of retinal and RPE metabolic function at the cellular level in normal human eyes with normal aging and age-related macular degeneration.